Perturbations of host cell signaling by a complex hepatotropic pathogen

ABSTRACT
During Plasmodium parasite liver stage infection, parasites protect their host hepatocyte by preventing its
death and exploiting host resources for growth and development. This process is imperfect, as some parasites
succumb to host defenses and are eliminated by host cell death; this, in turn, elicits an immune response. This
proposal is focused on the investigation of molecular mechanisms in the hepatocyte that curtail, or promote,
malaria parasite infection and the immunological consequences of those outcomes. After transmission by a
mosquito, Plasmodium parasites are carried by the blood stream to the liver and invade a single hepatocyte to
form a liver stage. Throughout the liver stage we have shown that both apoptosis and lipid peroxide mediated
death pathways curtail infection. Whether the infected cell survives or succumbs to host cell death has
consequences that expand beyond the individual infection; parasites that are eliminated via hepatocyte cell
death can provide potent stimuli for the subsequent immune response and the nature of the immune
stimulation is partially dependent on the type of regulated cell death engaged. Indeed, we show that immune
cell subsets, in particular immune cells with markers consistent with tolerogenic macrophages, sequester
around the parasite during liver infection. Additionally, eliminating apoptosis, a sterile form of cell death,
reduces immunity in response to whole parasite vaccination. This proposal aims to test the hypothesis that
multiple forms of cell death can control Plasmodium infection and that altering the balance between sterile and
inflammatory forms of cell death impacts subsequent immunity to parasite infection. To test this hypothesis, we
will make extensive use of animal and technological tools. First, we will use mice with cell death pathways
eliminated exclusively in hepatocytes to examine the specific role of each type of cell death in regulating wild
type parasites and parasites with multiple biological deficiencies. We will use genome wide CRISPR/Cas9
screens to identify specific genetic regulators of cell death in infected cells and we will make use of a mosquito
dissection robot that we have recently designed, built, and tested to perform larger, more unbiased analyses
than previously possible. We will also take advantage of state-of-the-art spatial profiling approaches that
facilitate the collection of proteomic and transcriptomic information in situ for Plasmodium-infected livers to
examine infected cells, and the surrounding immune environment. In addition to identifying mediators of initial
infection, will use these tools to ask how altered hepatocyte death primes CD8 T cell responses and informs
immunity to subsequent infection. Accomplishing our aims enables altering key host factors with small-
molecules that could prevent a wild-type parasite from progressing to symptomatic erythrocytic infection or
eliminate infection in a way that elicits a potent immune response against subsequent challenge.

Public health relevance
NARRATIVE The complex web of signals that arise from malaria parasite development within a host hepatocyte is highly medically relevant, as malaria kills more than half a million people annually. This proposal seeks to understand how malaria parasites overcome host cell death defenses, and how their inability to do so impacts subsequent immunity to infection.